Loss of progenitor function accelerates lung aging

Aging is associated with loss of lung structure and declining function. Emphysematous loss of tissue structure
is exacerbated by vasculopathy, which increases susceptibility to lung disease, and limits survival. We have
previously demonstrated that the structure and function of the lung microvasculature is regulated by a
specialized mesenchymal vascular progenitor cell (MVPC). We have also defined Dickkopf-related protein
1 (DKK1) as a regulator of this niche in murine and human model. Our preliminary data demonstrate that
MVPC numbers decline with age in WT mice by 1 year, and that, when MVPC are depleted in young mice,
lung aging is accelerated, resulting in severe emphysema at 1.5 years of age. While MVPC are key modulators
of the pulmonary microvasculature in the distal lung, adventitial stem cells (ASC) influence large blood vessel
homeostasis in the proximal lung. Our preliminary data identifies key similarities between MVPCs and ASCs
suggesting that decline in ASC numbers and function may also result in accelerated lung aging. Given ASC
function is tightly controlled by lung-resident type-2 innate lymphoid cells (ILC2) and pulmonary ILC2 are
known to decrease with age, loss of ASC-ILC2 crosstalk is likely a contributor to emphysema. Similar to aging,
vascular remodeling is driven by chronic activation of type 2 (Th2) inflammation. Our preliminary data support
increased Th2 cytokine profiles in plasma and BAL of COPD patients. Human and murine scRNAseq data
define ILC2 and MVPC populations as well as immune cell infiltrate and cytokine expression characteristic of
Th2 inflammation in COPD and a smoking model. The goal of this proposal is to define the mechanisms that
result in loss of adult MVPC and ILC2 progenitor function contributing to accelerated lung aging, by altering
vascular structure and function, and increased susceptibility to emphysema in the aged population. We
hypothesize that loss of progenitor function accelerates lung aging by altering cell interactions within vascular
niches, promoting vascular remodeling and increasing susceptibility to emphysema in the aging population. We
will test that decline in MVPC and ILC2 numbers and/or function in the aging lung accelerates aging via
impairment of vascular homeostasis due to disruption of cell – cell interactions in their respective perivascular
niches, promoting vascular remodeling and loss of tissue structure using novel conditional murine models to
knock down progenitors in aged mice or young mice. We will assess the requirement of MVPC, MVPC derived
DKK1, ILC2 cells, and ILC2 derived IL13 in the maintenance of vascular niche homeostasis and susceptibility
to emphysema. We will use conditional models to manipulate DKK1 or IL13 expression in mice allowed to age
in the presence or absence of cigarette smoke exposure both in vivo and in vitro. Lastly, we will test that loss of
ILC2 and MVPC progenitors promotes lung aging and is associated with COPD and a type-2 immune
endotype. This work will provide an understanding of progenitor aging, mechanisms by which loss of MVPC
and ILC2 function drives vascular remodeling with a Th2 endotype contributing to lung aging and emphysema.

Public health relevance
Aging is associated with loss of lung structure, declining function, and increased susceptibility to lung disease, together termed senile emphysema. The goal of this proposal is to define mechanisms that result in loss of adult mesenchymal vascular progenitor and innate lymphoid progenitor cell function, contributing to accelerated lung aging and increased susceptibility to emphysema in the aged population.